Organometallic Chemistry for Applications in Biomedical Sciences

DESCRIPTION (provided by applicant): Carbon-fluorine bond formation is a challenging chemical transformation, especially when used for the synthesis of arylfluorides. Simple molecules can be fluorinated with fluorination methods developed during the last 100 years, molecules of greater complexity, however, cannot. The current inability of chemists to efficiently make complex organic fluorides by late-stage fluorination often prevents research in diverse areas, such as drug development and molecular PET imaging. The proposed research addresses the chemical challenges of carbon-fluorine bond formation to synthesize functionalized arylfluorides. Our strategy for carbon-fluorine bond formation is based on organometallic chemistry. We proposed Pd- and Ag- mediated fluorination reaction of arylstannanes, arylboronic acids, and arylsilanes. Additionally we propose to develop transition metal fluoride complexes that react as electrophilic fluorination reagents using anionic fluoride as ultimate fluorine source. We further propose to synthesize four biologically active molecules via late-stage fluorination using our transition-metal mediated approach. A long-term-goal of our research is the application of our fluorination reactions to the synthesis of currently unavailable PET tracers for molecular imaging using positron-emission tomography. The application of the fluorination reactions to molecular imaging is beyond the scope of this grant proposal. PUBLIC HEALTH RELEVANCE: Many of the most useful man-made molecules contain fluorine due to the unique, desired properties of fluorinated molecules. The current inability of chemists to make complex fluorinated molecules by late-stage fluorination often prevents research in diverse areas such as drug development and molecular PET imaging.

Public health relevance
Relevance Many of the most useful man-made molecules contain fluorine due to the unique, desired properties of fluorinated molecules. The current inability of chemists to make complex fluorinated molecules by late-stage fluorination often prevents research in diverse areas such as drug development and molecular PET imaging.